Health Promotion and Disease Prevention Research Centers - 2019

Project Summary
For over 20 years, the Arizona Prevention Research Center (AzPRC) has provided an umbrella for academic
community collaborative research, training, capacity building, and translation efforts to reduce health
disparities in chronic disease in the state. The AzPRC foundation of practice-based research on chronic disease
prevention and control, with a focus on Latinos of Mexican-origin, well positions us to substantively contribute
to CDC’s winnable battle of nutrition, physical activity and obesity as well as addressing major national
disparities identified for diabetes. In doing so, AzPRC goals and objectives will carry forward existing efforts of
AzPRC personnel and partners to further the National Center for Chronic Disease Prevention and Health
Promotion’s mission “to support people and communities in preventing chronic disease and promoting health
for all”, specifically through our efforts to: 1) integrating evidence-based strategies in health systems including
health departments and federally qualified health centers; 2) working with public health systems and the
Community Health Worker (CHW) workforce to implement policy, systems & environmental change efforts
designed to create healthy places for people to work, learn and play; and 3) improving community-clinical
linkages to ensure access to, and quality of, culturally relevant prevention and promotion efforts. Over the next
five years the AzPRC will work with county health departments, federally qualified health centers, the Arizona
Department of Health Services, and community organizations to reduce chronic disease risk and address social
determinants of health statewide. The AzPRC will achieve this goal through the integrated impact of efforts in
infrastructure, community engagement, partnering and technical assistance, communication and
dissemination, training, evaluation and translation. The AzPRC, using state of the art and efficient
methodologies, will also execute a rigorous practice-based public health research project that will use leverage
existing resources and use group support processes to reduce chronic disease risk and address social
determinants of health. The project will also test a theoretical model of Latino health advantages and evaluate
potential novel assessment tools of potential integration in primary care and community health services. In the
latter stages of this research, guided by our prior successful statewide public health system-based efforts to
expand CHW intervention models, the sustainability and scalable of this program throughout the State will be
focal.

Public health relevance
Project Narrative Over the next five years, the Arizona Prevention Research Center will integrate evidence-based strategies across public health and health care delivery systems to expand policy, systems and environmental change efforts designed to create healthy places, and maximize community-clinical linkages to prevent chronic disease and promote health. Our Center activities and public health practice-based evidence research project will address major sources of health disparities in Arizona Latinos and the social determinants of health that contribute to them. Products from our center will lead to Community Health Worker strategies and programs to reduce chronic disease and address social determinants of health that are scalable and sustainable throughout the state and beyond.